Evaluation of Food Security Scales among Hispanic Parents: A Cognitive Interview and Psychometric Properties Study

PROJECT SUMMARY/ABSTRACT
A substantial segment of the 3.1 million Hispanic households that experience food insecurity (FI) consists of
predominantly Spanish-speaking immigrant parents with low or limited English proficiency. Yet, this population
has been excluded from survey development measuring FI. By excluding this population, we may not be
capturing how this population conceptualizes FI. Survey design limitations and lack of methodological rigor have
also prevented conceptual differences in food insecurity experiences from being measured in this dominant and
highly vulnerable US population. Current scales were constructed using translated items. While there are
methods to ensure accuracy of translated surveys, translations do not ensure participants understand survey
items. Due to literacy limitations, Spanish-speaking immigrant parents with low or limited English proficiency may
express their FI experiences differently from native English speakers. Consequently, the items on FI scales may
be interpreted differently from what the items were intended to measure. In addition, the most common Spanish
translated FI scale used in research (i.e. S-FSSM) is designed to capture a unidimensional experience of FI
rather than the multidimensional aspects that are established in the literature. The proposal seeks to address
these limitations by integrating how Spanish-speaking immigrant parents with low or limited English proficiency
conceptualize their FI experiences through an iterative process that includes individual concurrent cognitive
interviews (CI), group retrospective CI, and survey psychometric testing. The goal is to improve the clarity,
cultural, and linguistic appropriateness of words in the S-FSSM. Subsequently, this may lead to a multi-
dimensional scale that captures varied FI domains. Aim 1: Evaluate and adapt the current S-FSSM among
Spanish-speaking parents. Parents will provide feedback on FI experiences and the current scales through
individual concurrent CI (n=20) and group retrospective CI (n=20). The feedback will be used to revise the current
scales. Aim 2: Field test the revised scales and assess psychometric properties. A new set of Hispanic parents
(n=150) will complete the revised instruments. Exploratory factor analysis will examine structural validity. Internal
consistency reliability will assess how well the revised survey is measuring food security domains and test-retest
will assess stability over time. Convergent validity will be assessed via several outcome measures: parenting
stress, violence, health, and diet. The current proposal aligns with the Biden-Harris Administration's and NIH's
goal to end food and nutrition insecurity, and thus, significant. The use of a dominant population that is
traditionally excluded in survey development to assist in the advancement of a multi-dimensional scale is
innovative. The revised survey may assist in identifying additional Hispanic families who may benefit from the
Supplemental Nutrition Assistance Program (SNAP). SNAP participation has been associated with reducing FI
and negative health outcomes, and related to positive child health outcomes.

Public health relevance
PROJECT NARRATIVE Due to their literacy limitations, Spanish-speaking immigrant parents with low or limited English proficiency express their food insecurity experiences differently from native English speakers, and consequently may not interpret words on food insecurity surveys as they were intended to measure. Using a mixed methods approach, this study will integrate how Spanish-speaking immigrant parents with low or limited English proficiency conceptualize their food insecurity experiences to inform the development of a comprehensive food insecurity measure. This type of research is needed because there are over 3.1 million Hispanic households at elevated risk for experiencing food insecurity, some of whom may not be captured in the current measurement scales, placing them at risk for nutrition insecurity and various negative health outcomes.